A Deep Learning Model to Improve Pathologist Interpretation of Donor Kidney Biopsies

ABSTRACT More people die every year from kidney disease than breast or prostate cancer. Kidney transplantation is life-saving, yet the donor organ shortage and high organ discard rate contributes to 13 deaths daily among patients awaiting transplant. The decision to use or discard a donor kidney relies heavily on microscopic quantitation of chronic damage by pathologists. The current standard of care relies on a manual process that is subject to significant human variability and inefficiency, resulting in potentially healthy kidneys being discarded and potentially damaged kidneys being transplanted inappropriately. Our team developed the first Deep Learning model to quantify percent global glomerulosclerosis in donor kidney frozen section biopsy whole slide images. We developed a cloud-based platform to apply the Deep Learning model to analyze kidney biopsy whole slide images in under 6 minutes with accuracy and precision equal to or greater than current standard of care pathologists. We have also developed a Deep Learning model to quantify interstitial fibrosis on donor kidney biopsy whole slide images. This innovative approach has the potential to transform donor kidney biopsy evaluation by improving pathologist efficiency, accuracy, and precision ultimately resulting in optimized donor organ utilization, improved patient outcomes, and diminished health care costs. The goal of this project is to establish our Deep Learning automated techniques as the standard for evaluating donor kidneys prior to transplantation. This will be achieved by assembling a team of expert pathologists and computer scientists specializing in machine learning. The proposal will evaluate the accuracy and precision of the interstitial fibrosis Deep Learning model, use the automated quantitation of key microscopic findings to develop an outcome-based chronic damage score that predicts graft outcome, and test the ability of the Deep Learning models to withstand variations encountered using different scanners and processing in different laboratories. The functionality of the Trusted Kidney software platform will be improved beyond the current usable product into a commercially viable solution for multiple laboratories.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Before kidneys can be transplanted, they must be examined using a microscope to ensure the kidney is healthy enough for transplant. A limitation of microscopic examination by pathologists is the inherent human variability in quantifying the amount of scar tissue, or chronic damage, present. The result is potentially healthy organs being discarded or damaged kidneys being used inappropriately. This funding will support developing artificial intelligence tools to assist pathologists with quantifying scar tissue in donor kidneys prior to transplantation, resulting in more consistent and objective biopsy evaluations, minimizing discard of potentially healthy kidneys, and optimizing placement of kidneys for transplant.